CSF1R Signaling in Age-Related HIV Neurodegeneration

Project Summary
Despite the advent of highly active antiretroviral therapy, HIV-associated neurocognitive disorders (HAND)
remain surprisingly common. As treated HIV patients have been living longer, the HIV-infected population is
aging rapidly. Since older age (>50 years old) is a major risk factor for HAND, there is a growing concern
about the possibility of a much greater prevalence of HAND in the next few decades in the United States and
globally. Moreover, aging HIV patients are now also facing a new risk of developing Alzheimer’s disease (AD).
All these (the aging HIV population with an alarming prevalence of HAND in the absence of effective treatment
and the possibility of an impending epidemic of AD, HAND or combination) highlight the urgent need for
greater understanding of the pathogenesis of this disease. The principal challenge in HAND and AD research
is a paucity of clinically more relevant animal models to study the mechanisms of pathogenesis and evaluate
therapeutics. The overall goal of this supplement is to determine if aging rhesus macaques with SIV+ART that
are undergoing accelerated aging, develop neuroinflammation and brain lesions suggestive of AD-like disease
processes. The significance of this supplement is that if overlapping pathways in inflammatory or AD-related
biomarkers and similar lesions are observed, this would contribute to hypothesis-driven proposal for validation
of related mechanisms between SIV/HIV and AD disease, new model development for AD, and identification of
converging pathways of pathogenesis for identifying targets of intervention.

Public health relevance
Project Narrative The proposed research is relevant to public health because the discovery of the mechanisms of HIV persistence in the central nervous system (CNS) will help develop novel therapeutic strategies to eradicate HIV from the CNS of infected individuals receiving highly active antiretroviral therapy. This project proposes to investigate whether long-lived brain macrophages expressing high levels of colony-stimulating factor 1 receptor (CSF1R) is the major cellular reservoir of virus in the CNS during acute and chronic infection in the setting of antiretroviral therapy and whether targeting of this cell type by pharmacological inhibition of CSF1R will reduce or even eliminate virus infection of the CNS.